DNA-gated cytometry for multiplexed sorting of antigen-specific CD8 T cells

PROJECT SUMMARY
Ag-specific CD8 T cells express T cell receptors (TCRs) that recognize antigens in the form of processed
peptides bound to major histocompatibility complex class I (MHCI) molecules. In healthy individuals, the CD8
TCR repertoire comprises approximately 106–108 different cell populations. Soluble pMHCI multimers are widely
used to enumerate and isolate Ag-specific T cells by fluorescence activated cell sorting (FACS); however, FACS
has limitations including low-throughput, high shear-stress damage (especially to rare cells), and low multiplexing
depth due to limited number of fluorophores. For high-throughput cell sorting (>106 cells) such as for
manufacturing T cell therapies, magnetic activated cell sorting (MACS) is commonly used but can only produce
antibody-enriched or depleted cell fractions, and cells sorted by positive selection remain labeled with beads,
preventing immediate downstream assays such as phenotyping by flow analysis. New approaches are needed
for multiplexed, high-throughput and label-free isolation of Ag-specific T cells. This proposal will develop DNA-
gated sorting (DGS) cytometry for multiplexed isolation of Ag-specific CD8 T cells. DGS comprise a molecular
DNA circuit that couples a magnetic bead to pMHCI molecules through DNA hybridization, and that functions as
a sorting ‘gate’ to capture, release, and recover Ag-specific T cells by toehold-mediated strand displacement. By
using orthogonal DNA strand displacement reactions, a library of beads coated with different pMHCI antigens
can simultaneously capture target cell populations en masse and each subpopulation can then be eluted by
sequential strand displacement. In contrast to fluorophores, the number of possible DNA sequences to design
strand displacement reactions scales exponentially by the length n of the DNA oligo (i.e., 4n), providing the
possibility to extend this technology to isolate Ag-specific T cells at depths that is currently not possible. This
proposal will also implement DGS with pMHCI monomers that multimerize when hybridized onto the bead to
produce the required binding avidity for T cell capture, but after cell release, revert into monomers to dissociate
from T cells resulting in label-free isolates. It will also implement light-induced peptide exchange to produce large
pMHCI libraries to integrate with multiplexed DGS. Finally, this proposal will demonstrate an important
application for the manufacturing of chimeric antigen receptor (CAR) T cells using virus-specific T cells to redirect
them to tumor cells, using key benchmarks such as ex vivo functional assays (expansion, transduction efficiency,
cytotoxicity) and in vivo therapy in mice bearing CD19+ cancer cells.

Public health relevance
PROJECT NARRATIVE Antigen-specific CD8 T cells are key players in adaptive immunity and have transformative applications as cell therapies. Yet isolating these cells is challenging because of their receptor diversity and rarity. We propose to develop DNA-gated cytometry for multiplexed sorting of Ag-specific CD8 T cells to overcome current challenges.